Function and regulation of copper in mammalian tissue differentiation

PROJECT SUMMARY/ABSTRACT
Mammalian tissue development requires a series of tightly regulated and dynamic fluctuations
in metabolic pathways, growth factor signaling, gene expression, and cofactor availability. An
important cofactor is copper (Cu), an essential but toxic trace nutrient that is required for oxidative
phosphorylation, removal of reactive oxygen species, iron homeostasis, and pro-survival
signaling pathways. Cu is important for normal tissue development, and we and others have
shown that Cu is required for differentiation of skeletal muscle and neuronal cells. This need for
Cu is highlighted by the severe postnatal developmental impairment in cases of Cu deficiency
including profound hypotonia and neurodegeneration. Menkes is a fatal genetic Cu deficiency
disease caused by mutations in ATP7A, which encodes a trans-Golgi Cu transporting ATPase.
Several open questions remain about the critical Cu targets during tissue differentiation and how
regulated gene expression contributes to prioritized Cu distribution to those targets. These
questions create a gap in knowledge of Cu handling that limit the development of therapies to
treat Cu diseases including Menkes. Our preliminary data indicate that ATP7A is required for
skeletal muscle cell differentiation and that Cu and ATP7A may contribute to regulated inhibition
of TGF- signaling pathways that prevent differentiation. We also discovered that post-
transcriptional regulation of the Atp7a RNA contributes to differentiation-dependent tuning of
ATP7A expression. The proposed research program includes two projects to understand
prioritization of Cu during skeletal muscle differentiation by first focusing on function and
regulation of ATP7A. The first project will study the role of Cu and ATP7A in modulating TGF-
signaling to promote differentiation in vitro and in vivo. The second will focus on uncovering the
mechanisms of post-transcriptional regulation of Atp7a RNA and how they control ATP7A
expression. These projects will identify new signaling pathways regulated by Cu and new
mechanisms of Cu regulation. This work will open the possibility of modulating Cu availability by
targeting post-transcriptional regulatory pathways and raise the possibility of controlling TGF-
signaling by manipulating Cu availability to treat Cu-related and developmental disease.

Public health relevance
PROJECT NARRATIVE Copper is an essential trace nutrient important for fundamental processes including respiration, removal of toxic oxygen radicals, cell signaling, and tissue development. Copper is also toxic, and impaired import and distribution is associated with a number of human diseases including Menkes disease, a fatal genetic Cu deficiency that is characterized by severe postnatal developmental defects. These studies focus on gaining a deeper knowledge of how cells balance copper levels during dynamic states like tissue development by focusing on how the copper is prioritized to control the signaling pathways that promote or inhibit development and how expression of genes regulating Cu import and distribution are regulated.